The Gut as a Target to Improve Outcomes in Sepsis

Sepsis is the leading cause of death among critically ill patients in the United States, and costs of sepsis for
Medicare beneficiaries exceed $62 billion annually. Outside of antibiotics, treatment for sepsis is non-specific,
and there are no approved therapeutics available once antibiotics and supportive therapy fail. Patients with
cancer are nearly ten times more likely to develop sepsis than the general population, and cancer represents
the most common co-morbidity in septic patients. Moreover, cancer is the co-morbidity associated with the
highest risk of death in sepsis, and the increased mortality is seen disproportionately in younger adult patients.
The gut has long been characterized as the motor of multiple organ dysfunction syndrome. All major elements
of gut integrity are altered in sepsis, with dysregulation in the epithelium (permeability, apoptosis, proliferation,
migration), the microbiome and the mucosal immune system. Further, both immunity and gut integrity are
disproportionately impacted in cancer/sepsis hosts compared to previously healthy/sepsis hosts. This program
seeks to understand mechanisms underlying dysregulated gut integrity in sepsis. The first approach will be to
examine what happens within the epithelium, the mucosal immune system and the microbiome, to elucidate
mechanisms of sepsis-induced intestinal alterations within individual processes in isolation. The next approach
will be to examine crosstalk between the three broad components of the gut since each element directly
impacts each other, leading to further alterations in all. The final approach will be to examine how the gut leads
to extra-intestinal effects on distant organs, where gut-derived changes lead to subcellular, cellular and organ
dysfunction, resulting in worsened morbidity and mortality. Additionally, the program seeks to understand why
outcomes are different in cancer/sepsis, by examining differences seen in both the adaptive immune system
and gut integrity. A “one size fits all” approach to an inherently heterogeneous syndrome is likely a key reason
why more progress has not been made in decreasing mortality from sepsis clinically, and the goal of
understanding mechanisms of how a chronic co-morbidity leads to different outcomes at the bedside is to
move towards precision medicine in septic patients. The program will use human samples (gut, blood and
stool) paired when feasible with clinical data and outcomes. Mechanistic questions will then be approached
using a bedside to bench paradigm whereby insights obtained examining human samples will then be
evaluated using a variety of in vivo and in vitro techniques when experiments cannot be performed in patients.
Since the gut plays a major role in both initiating and propagating critical illness and co-morbidities play a
crucial role in worsening outcomes in septic patients, understanding mechanisms through which gut integrity is
dysregulated in sepsis especially in hosts with cancer has significant public health implications in a disease
that is common, very costly, and highly lethal.

Public health relevance
Gut integrity is markedly worsened following sepsis, the leading cause of death among critically ill patients. Cancer is the most common comorbidity in sepsis, and the presence of malignancy results in significant alterations in both immunity and gut integrity. This program seeks to understand mechanisms through which sepsis alters gut integrity and through which cancer worsens outcomes in order to uncover new potential therapeutic targets to improve outcomes in a disease that is very common and highly lethal.